Behavioral Modulation of Cortical Responses During Complex Sound Perception

DESCRIPTION (provided by applicant): A fundamental question in auditory neuroscience is how neural activity in the cerebral cortex gives rise to perception and how changes in brain activity relate to different behavioral states. Activity in primary auditory cortex has been shown to be modulated by engagement in a psychophysical task, but relatively little is known about the causal links between neural activity and perception and how different behavioral states modulate various cortical areas at both the single neuron and population level - especially for non-primary auditory areas. The experiments in this proposal will use a powerful combination of multi-channel neurophysiological techniques and behavioral testing to examine the links between neural activity in auditory cortex and perception at both the individual neuron and population levels in marmosets. Specific Aim 1 examines and compares behavioral modulation of neural responses between two auditory cortical areas. Specific Aim 2 focuses on the correlation between neural responses and marmoset's perception of pitch-bearing harmonic complex tones in the pitch region of auditory cortex. Results of the experiments described here will contribute greatly to our understanding of the perceptual organization of complex sounds and their physiological underpinnings in marmosets. These experiments will also help to elucidate the functional organization of different levels of the auditory cortical hierarchy. Finaly, because of the close phylogenetic relationship between human and nonhuman primates, these results will provide a better understanding of complex sound processing, including speech perception, in human auditory cortex.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project seeks to describe the perception and processing of complex sounds by marmoset monkeys using a novel combination of behavioral and neurophysiological methods. The experiments described in this proposal will greatly enhance our knowledge of sound processing abilities in primates - specifically how behavior modulates neural activity at both the single neuron and population levels. This project represents the beginning of a movement toward using psychophysical and behavioral methods combined with neurophysiology in the attempt to ultimately develop a neuroethological model of auditory perception in primates.